Core C: Data Management and Statistical Core

ABSTRACT – DATA MANAGEMENT AND STATISTICAL CORE
The Data Management and Statistical Core (Data/Stat Core) of the proposed Rush ADRC will design and
maintain systems to support the acquisition, maintenance, distribution and analysis of high-quality data to be
collected by the Clinical, Religious Orders Study, Latino, and Neuropathology Cores of the ADRC and the
processing of image files by the Biomarker/Neuroimaging Core. These data will be a resource for research on
normal aging, MCI, Alzheimer’s Disease, and Alzheimer’s Disease-Related Dementias (AD/ADRD).
The Data Management and Statistical Core will support the other cores in the Center by (1) maintaining a
center-wide system of random subject ID numbers, (2) maintaining PC- and web-based electronic data
collection systems for each core to collect data, (3) processing and maintaining item-level data in a secure
relational database management system, (4) managing storage of high throughput files containing biochemical
and molecular data, (5) storing computed summary variables in a secure relational database management
system, (6) providing flexible, comprehensive, automatic and timely status reports for study coordination, and
(7) designing, maintaining and tracking usage of the Center’s internal and external websites. The Data/Stat
Core will also maintain tracking systems for (1) scheduling and prioritizing study participants and biospecimens
for the Clinical, Religious Order Study, and Latino Cores, (2) tracking biospecimen inventory and requests for
distributions for the Neuropathology and Administrative Cores, (3) tracking data requests and distributions for
the Administrative Core, (4) tracking activities and outcomes for the Outreach, Recruitment, and Engagement
Core and for the Research Education Component, (5) tracking publications using Rush ADRC resources, and
(6) prioritization of data management and statistics activities.
The Core will provide expert statistical assistance with design and analysis to Rush ADRC investigators and
developmental project applicants and awardees, and more limited guidance to independently funded studies
that utilize Rush ADRC data and/or specimens.
The Core will support systems for providing data and biospecimens to NIA-sponsored repositories (such as
NACC, NCRAD, NIAGADS, AMP-AD) and to externally funded projects and secondary analyses, with an
emphasis on projects funded by the National Institutes of Health and other reputable research organizations.
The Data/Stat Core will maintain an online system for investigators inside or outside the Rush ADRC to submit
requests for Rush ADRC data and biospecimens. The Core will maintain tools that extract approved datasets
for distribution, and generate accompanying clear and accurate data element dictionaries so as to support
open science and innovative research on the etiology, pathogenesis, diagnosis, treatment and prevention of
Alzheimer’s disease and Alzheimer's disease-related dementias (AD/ADRD).